Chemical Glycobiology Tool Development: LYTACs

Project Abstract
Lysosome targeted chimeras (LYTACs) are a recently developed technology that enable targeted
internalization and subsequent degradation of a cell surface antigen by engaging the cation- independent
mannose-6-phosphate receptor (CI-M6PR). The modular design of LYTACs enable its implementation in
other therapeutic antibody-based modalities including antibody-drug conjugates (ADCs). We will develop
ADC/LYTACs, which consist of an ADC conjugated to CI-M6PR binding ligands, which will provide a
supplemental internalization and efficient lysosomal trafficking route independent of the inherent
characteristics of a tumor antigen. To reduce off-target cytotoxicity, the CI- M6PR binder will be carefully
optimized and a two-component strategy will be tested where the tumor antigen is pre-treated by a non-
internalizing ADC before clicking on the internalizing ligand in vitro. Further, prodrug analogues of the CI-
M6PR ligand will be developed to enhance the pharmacokinetic properties of this new therapeutic
modality. We envision that ADC/LYTACs will significantly expand the target space for ADCs to include
highly specific yet poorly internalizing tumor antigens.

Public health relevance
Project Narrative LYTACs enable the degradation of oncogenic cell surface proteins by engaging CI-M6PR, a receptor that shuttles its cargo to the lysosome. The proposed project will combine LYTAC technology with antibody- drug conjugates that target non-internalizing tumor antigens which are currently poor candidates for ADC therapy. ADC/LYTACs can be generated via standard antibody conjugation methods, representing a generalizable strategy across different ADC platforms.